Impact of post-stroke rehabilitation on neurophysiological dynamics

SUMMARY/ABSTRACT
The long-term goal of this project is to develop a novel mechanistic framework to understand how post-stroke
rehabilitative training modulates neural reorganization in sensorimotor brain regions, and whether such
reorganization is associated with recovery of motor function. In a non-human primate model of capsular stroke,
we will describe the time course of changes in task-related motor encoding and mesoscale cortico-cortical
connectivity that occur in sensorimotor brain regions, and the time course of these changes in relation to motor
recovery. These neurophysiological changes will be compared to those occurring in animals undergoing
intensive rehabilitation initiated in the sub-acute stage after injury. Post-stroke neural plasticity has been
demonstrated repeatedly in pre-clinical and clinical studies. Animal studies have provided key information
regarding the molecular mechanisms of synaptic plasticity, and focal cortical stroke models have demonstrated
that alterations in neuronal connectivity are correlated with functional recovery. However, most studies are cross-
sectional and cannot address the complex temporal relationships between neural plasticity and behavioral
recovery; conclusions about the impact of rehabilitation on recovery mechanisms, and ultimately on clinical
recovery, are largely correlative. As a result, it is currently unknown whether plasticity mechanisms demonstrated
in most clinical and preclinical studies are associated with the initiation of recovery processes or are the result
of behavioral recovery. Further, when longitudinal studies in clinical populations have been done, relationships
between plasticity and motor recovery have been equivocal, in part because fMRI-based approaches lack the
temporal specificity to resolve the intricate patterns of communication among brain regions that are essential for
normal sensorimotor function. Using chronic microelectrode arrays in a longitudinal experimental design, we will
address three specific aims that examine neural activity (extracellular spikes) simultaneously recorded from
multiple cortical sensorimotor areas and motor thalamus before and after capsular infarct. This will allow us to
examine how stroke-like injuries disrupt task-related motor encoding in somatosensory and motor cortical areas
using traditional dynamical structure models (Aim 1). Further, we will characterize the impact of capsular infarcts
on mesoscale effective connectivity using a novel neurophysiological approach that we recently developed (Aim
2). Finally, we will determine whether rehabilitative training procedures initiated in the sub-acute period after
neural injury influence recovery by modulating task-related activity, altering effective connectivity, or both (Aim
3). The novelty and potential impact of this project stems from the unique longitudinal design, providing us with
the ability to plot the precise temporal profile of local and networked changes to determine if a particular
biomarker precedes rehabilitation-aided recovery, and thus, is more likely to have a direct causal relationship
with functional restoration. Achieving these goals ultimately will inform clinical studies aimed at personalizing
post-stroke rehabilitation based on neurophysiological biomarkers of recovery potential.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because brain injuries, such as occur in stroke, leave many people with chronic motor disabilities, requiring long-term medical and institutional care. This project seeks to develop a greater understanding of the plasticity process that occurs after brain injury, specifically in the compensatory functional connections that form in uninjured regions of the brain. Information gained from this project will inform the development of new therapies, such as rehabilitative approaches designed to maximize functional recovery after brain injury.